Vermont State Produce Safety Program: Design, Development & Implementation

Project Summary/Abstract Project Title: Vermont State Produce Safety Program: Design, Development & Implementation Project Description: The Vermont Agency of Agriculture, Food & Markets (VAAFM) will establish a produce safety program to encourage the production of quality, safe fruits and vegetables, ensure producer competitiveness in the marketplace, and assist FDA in implementing the FSMA-mandated, unified partnership approach toward achieving an integrated food safety system. Project Goals: The proposed project will establish and utilize a multi-year strategic plan to identify resources needed to implement a produce safety program aligned with FDA’s Produce Safety Rule (PSR)—including metrics to evaluate its effectiveness—and to develop an inspectional program that meets FDA requirements and promotes public health. This program will include education and training for produce farmers covered under the rule as well as robust training for regulators. Expected Outcomes: The partnerships and plans to emerge from this work will create a federal-state relationship that will leverage the existing and future expertise, knowledge, and resources committed to education and implementation of the PSR in Vermont. Project Objectives: (1) Self-Assessment: conduct a self-assessment of components necessary to create an education and technical assistance and inspectional program. (2) Farm Inventory: establish a mechanism to develop an inventory of Vermont farms subject to the PSR, utilizing relationship development with the produce industry through offering technical assistance, market access, and capital infrastructure support to populate and sustain this inventory. (3) Legal Authority: Evaluate existing regulatory authority related to produce safety and the changes necessary to establish, operate, and maintain a program aligned with the requirements of the PSR. (4) Program Infrastructure: Invest in the sustainable implementation of a program that includes inspection and compliance activities, technical assistance and industry support, producer and regulator training opportunities, and a robust evaluation process. (5) Education, Outreach & Technical Assistance: Promote the development of an educated and informed Vermont produce grower community resulting in knowledge of the Produce Safety Rule and how to achieve compliance. (6) Communication Plan: Develop a communication plan for outreach to industry, partners, and the public about programmatic strategy, implementation efforts, and measurable outcomes. Budget: Year 1: $500,000; Year 2: $725,000; Year 3: $755,000; Year 4: $770,000; Year 5: $875,000 Total: $3,625,000 for the five-year cooperative agreement period

Public health relevance
Project Narrative Project Title: Vermont State Produce Safety Program: Design, Development & Implementation This Vermont Agency of Agriculture, Food, and Markets (VAAFM) project entitled Vermont State Produce Safety Program: Design, Development & Implementation intends to establish a produce safety program that will encourage the production of high quality and safe fruits and vegetables, ensure competitiveness in the marketplace for our producers, and at the same time assist the U.S. Food and Drug Administration (FDA) in accomplishing the FSMA-mandated, unified partnership approach toward achieving compliance with food safety regulations. To establish the program, VAAFM will:  Create and utilize a multi-year strategic plan that identifies resources needed to implement a produce safety program, that aligns with FDA’s Produce Safety Rule, and that contains metrics and outcomes to evaluate its effectiveness.  Develop a state-level produce safety inspectional program that meets FDA requirements and supports public health. VAAFM will undergo a comprehensive self-assessment to determine the components needed to create a regulatory and enforcement program, which includes conducting legislative research and infrastructure development along with determining organizational structure and human resources needed.  Establish a strong education and technical assistance component to the regulatory program that ensures producers feel educated and supported with tools to achieve compliance with the Produce Safety Rule.  Implement a program that includes Produce Safety Rule education and training for produce farmers covered under the rule as well as robust regulator training for our VAAFM staff. These four goals will significantly advance a national integrated food safety system (IFSS) and effectively fulfill the requirements of FDA’s Produce Safety Rule in Vermont.